Structural Basis for HIV-1 Rev Nucleocytoplasmic Trafficking

Abstract
Human immunodeficiency virus 1 (HIV-1) targets the human immune system and can lead to the development
of acquired immunodeficiency syndrome (AIDS), increasing susceptibility to opportunistic infections and tumors.
Current HIV-1/AIDS treatments involve the utilization of combination antiretroviral therapies (cART) that target
and inhibit multiple steps of the HIV-1 replication cycle. People living with HIV must stay on treatment for the rest
of their lives, which increases the risk of HIV-1 developing resistance to antiretrovirals. As a result, there is a
need for the development of novel antiretrovirals. One target for possible antiretroviral treatment is the HIV-1
protein called Rev (regulator of expression of virion proteins). Rev functions as a nucleocytoplasmic shuttling
protein for the nuclear export of viral mRNA necessary for virus assembly. To properly mediate the export of this
mRNA, Rev must be able to translocate back and forth through the nuclear pore complex (NPC). Rev contains
a nuclear localization signal and a nuclear export signal able to bind host importins and exportins, which are
responsible for host cargo nucleocytoplasmic trafficking. This F31 proposal seeks to decipher how HIV-1 Rev is
recognized, bound, and trafficked through the NPC by the host nuclear transport machinery. We hypothesize
that Rev hijacks human importins and exportins, specifically importin-β and Crm1 (or exportin), for trafficking Rev
through the NPC and preventing Rev aggregation and non-specific RNA binding. Aim 1 of this proposal explores
binding determinants between HIV-1 Rev and importin-β. We will utilize cryogenic-electron microscopy (cryo-EM)
and pull-down and turbidity assays to visualize and characterize the importin-β:Rev structure. Aim 2 explores
the mechanisms of Crm1 nuclear export of Rev alone and bound to the HIV-1 genome. To better understand
these mechanisms, we will use cryo-EM to determine the structures of Crm1 bound to Rev before and after
adding viral mRNA.

Public health relevance
Project Narrative Human immunodeficiency virus-1 (HIV-1), the etiological agent of acquired immunodeficiency syndrome (AIDS), causes substantial morbidity and mortality worldwide. This proposal seeks to elucidate how HIV-1 Rev hijacks the host nuclear transport machinery to promote viral replication. These studies will fill conceptual gaps in HIV- 1 biology, thus providing new opportunities for pharmacological intervention and developing new antivirals.